Direct-to-family pharmacokinetics intervention for hydroxychloroquine non-adherence in adolescents with systemic lupus erythematosus

PROJECT SUMMARY/ABSTRACT
Half of adolescents with pediatric systemic lupus erythematosus (pSLE) do not take medications regularly as
prescribed. Non-adherence increases the risk of uncontrolled disease and poor health outcomes. Non-
adherence to hydroxychloroquine (HCQ), a highly effective medication recommended for nearly all patients
with pSLE, is especially difficult to identify due to the poor predictive performance of available measures. To
identify and ultimately reduce HCQ non-adherence in pSLE, I propose to: 1) use pharmacokinetic model
simulations to define an HCQ concentration cutoff as an objective measure of non-adherence; 2) develop a
novel, patient-facing digital intervention that delivers personalized feedback on HCQ concentrations to promote
taking HCQ as prescribed; and 3) test feasibility and preliminary efficacy of the intervention in 25 adolescents
with pSLE. Results will provide a non-adherence cutoff that will be immediately useful to identify non-
adherence in clinical care. Results will also generate preliminary data to plan a larger efficacy trial designed to
reduce non-adherence. The Mentored Career Development Award will provide the dedicated time, structured
training, and mentorship required to advance my existing clinical pharmacology, analytic, and trial skills and
develop new skills in digital interventions. My overarching career goal is to optimize therapeutics to improve
health outcomes in pSLE and other pediatric rheumatic diseases using patient-centric methods. By completing
the proposed research and training plans within the world-class research environment at Duke, I will acquire
the skills and experience necessary to apply for independent funding and launch an academic research career
dedicated to optimizing treatment and improving health outcomes in pediatric rheumatic diseases.

Public health relevance
PROJECT NARRATIVE Half of adolescents who suffer from pediatric systemic lupus erythematosus do not take medications regularly as prescribed and face high risk of poor health outcomes. Though critically important to health outcomes, non- adherence is often difficult to identify in research and clinical care settings using existing measures. This proposal will use pharmacokinetic model simulations to define a blood concentration predictive of non- adherence, and then develop and pilot test a novel, patient-facing intervention designed to reduce non- adherence in pediatric systemic lupus erythematosus.